RAPID RESPONSE TO ANTIDEPRESSANTS IN SLEEP DEPRIVATION

To establish that one night's sleep deprivation will produce a rapid, sustained response to antidepressant drugs initiated at the same time in about 50% of depressed subjects; and to determine whether or not baseline thyroid function will predict response to antidepressants and SD.